IN VIVO ANALYSIS OF T CELL TURNOVER IN RHESUS MACAQUES

The kinetics of lymphocyte turnover in primates is poorly understood. Studies in HIV infected individuals treated with anti retrovirals have been used to predict the turnover rate for CD4+ cells. Studies in mice have incorporated the uptake of bromodeoxyuridine (BrdU) together with surface phenotyping to determine rates of lymphocyte turnover. We have developed a system whereby rhesus macaques are dosed with BrdU via the intraperitoneal or oral routes, and various lymphocyte subsets can be tracked via FACS analysis. Both naive (CD45RA+Leu8+) and memory subsets of CD4+ and CD8+ T cells have been identified in the BrdU labeled subset of cells. Consistent with studies in mice and humans, we observed more rapid turnover of memory than naive T cells. Use of this technique will permit direct measurement of T cell turnover in SIV-infected macaques.